CSR&D Research Career Scientist Award Application

Dr. Tregellas’ research career has focused on the neurobiology of schizophrenia, a leading cause
of disability for Veterans. Much of this research is focused on low-level sensory processing deficits and
hippocampal hyperactivity, which is now considered a core feature of the illness. In addition to work
examining various contexts in which hippocampal hyperactivity is observed in schizophrenia, Dr. Tregellas
has explored the effect of this activity on other cognitive processes and is actively engaged in therapeutic
development. Initially with nicotinic agonists, and now with other potential therapeutic strategies, he is
leading efforts to target hippocampal hyperactivity as a means to improve treatments for the symptoms of
schizophrenia. In his current project, Dr. Tregellas is determining if low-lose levetiracetam, an
anticonvulsant agent typically used to control seizures, may reduce hippocampal hyperactivity in patients.
This strategy originally was motivated not only by the fact that levetiracetam effectively reduces neuronal
excitability in epilepsy, but also that low doses of the agent were shown to reduce neuronal activity in
individuals with mild cognitive impairment, who also show excessive activity in the hippocampus. After
initial studies showing that the agent reduces a measure of neuronal excitability in a mouse model of
schizophrenia, Dr. Tregellas is now in the initial stages of a human clinical trial to determine if
levetiracetam can reduce hippocampal hyperactivity and improve cognition in Veterans with
schizophrenia. This work is currently funded by a VA Merit Review Award and a VA Research Career
Scientist Award.
In addition to work examining the neurobiology of schizophrenia, Dr. Tregellas is also interested in
understanding how current treatments for schizophrenia cause weight gain and metabolic problems in
patients. Toward this end, he has an NIH R01 to study the neuronal processes of antipsychotic-induced
weight gain, and to examine the effects of exercise on these processes in patients. Specifically, this study
examines the neuronal effects of antipsychotics associated with a high risk of weight gain, compared to
treatments associated with a low risk of weight gain. Coupled with this, Dr. Tregellas also is studying the
effects of a 12-week exercise intervention on neuronal responses associated with food intake behavior.
Related to this work, Dr. Tregellas also is interested in understanding the neurobiology of obesity in the
general population. With his VA collaborator Dr. Marc Cornier, Dr. Tregellas has performed and published
a series of studies examining differences in neuronal response in individuals prone or resistant to obesity.
Many of these studies have examined responses to changes in energy intake or expenditure. In his
current work on this topic, Dr. Tregellas is leveraging an observation from his schizophrenia work, that an
alpha-7 nicotinic agonist causes reduced neuronal response in some of the same networks that he had
previously found to be hyperactive in individuals with obesity. This finding, along with an observed effect
of drug on weight in the schizophrenia work, led to an NIH R01-funded study of the effects of an alpha-7
nicotinic agonist on neurobiological and behavioral processes related to obesity in the general population.
The aim of this work is to better understand the neurobiology of obesity and develop treatments to reduce
its prevalence, a goal of vital importance to the VA.

Public health relevance
Schizophrenia is a leading cause of disability for Veterans, but remains poorly treated. A primary focus of Dr. Tregellas’ research is developing a better understanding of the neurobiology underlying schizophrenia and developing new, more effective treatments for the illness. Much of this work is aimed at reducing activity of the hippocampus, which is now considered a core feature of schizophrenia. Dr. Tregellas’ current study is determining if low-dose levetiracetam , typically used at higher doses to treat seizures, can reduce hippocampal activity and improve schizophrenia symptoms. He also is interested in how antipsychotic medications used to treat schizophrenia symptoms cause weight gain and metabolic problems in patients, and how exercise might alter these effects. Related to this, Dr. Tregellas is interested in understanding the neurobiology of obesity not only in schizophrenia, but also in non-mentally ill Veterans, who have obesity rates substantially higher than in the general population.